A new epigenetic toolbox for inflammation research and drug discovery

PROJECT SUMMARY
Gene regulation is controlled in part by histone post-translational modifications (PTMs) on nucleosomes.
EpiCypher® is developing fully defined recombinant designer nucleosomes (dNucs) carrying specific histone
PTMs to enable epigenetics research and drug development. The power of EpiCypher’s dNuc platform comes
from its broad chemical diversity. EpiCypher has commercialized > 100 unique dNucs, covering the most widely
studied PTM classes (e.g. lysine methylation / acylation / ubiquitylation, arginine methylation, serine
phosphorylation, etc.) and is leveraging the emergent property of this diversity for a range of high value
applications: 1) antibody specificity testing (NucleoPlex® antibody validation: e.g. chromatinantibodies.com); 2)
ultra-sensitive genomic mapping (CUTANA® CUT&RUN / CUT&Tag assays); and 3) high-throughput
biochemical approaches for drug discovery and inhibitor screening (dCypher® assays). To date, EpiCypher’s
dNuc technology (and related assay platforms) have been focused on PTMs with known associations with
chromatin states and gene regulation. Relying on the field’s largely descriptive histone PTM studies as a guide
is an inefficient way for us to expand our discovery platforms and maximize the potential of our nucleosome
generating capability to target the most functionally important PTMs. Progress on the discovery side has been
hindered by intractability of the multi-copy histone genes for functional genetics studies in mammals (vs. simpler
model organisms). Here, EpiCypher is partnering with Dr. Steven Josefowicz (Weill Cornell Medical
School) to expand epigenetic tool development for immunology research and biomarker discovery. The
innovation of this project is employment of a first-in-class mammalian histone variant H3.3 genetic replacement
method to identify orphaned / underappreciated residues (and PTMs) with roles in macrophage stimulation. We
will then develop new dNucs containing these PTMs and validate their role in macrophage function. For proof of
concept, we developed the histone replacement assay to characterize the role of some highly studied (e.g.
H3.3K4, H3.3K36) and underappreciated (H3.3S31) residues in the macrophage stimulation response, and
showed the resulting data can immediately be used to guide the delivery of new epigenetic reagents and assays
to support the study of immune system function and disease. In Phase II, we will leverage this development
pipeline to identify novel resides vital for macrophage stimulation (Aim 1). Next, we will develop a collection of
dNucs carrying PTMs on these resides, which will be used in NucleoPlex assays to identify best-in-class
antibodies to each target (Aim 2). Finally, we will validate the function of these novel PTMs in immune cell
stimulation using CUT&Tag assays as well as share our expanded reagents and capabilities with key opinion
leaders for external validation (Aim 3) Together, this work will result in the commercialization of an
expanded epigenetics toolbox that will open new avenues of immunological research and drug
development.

Public health relevance
PROJECT NARRATIVE Gene regulation is controlled in part by histone post-translational modifications (PTMs) on nucleosomes. EpiCypher® is developing fully defined semi-synthetic designer nucleosomes (dNucs) carrying specific histone PTMs for a range of high value applications from biochemical assays to epigenomic mapping. Despite our progress, dNuc technology (and related assay platforms) largely has been restricted to PTMs with previously characterized roles in gene regulation / disease. The goal of this study is to identify new or orphaned (i.e. understudied) histone PTMs with major roles in macrophage biology. This will expand EpiCypher’s cutting-edge epigenetics toolbox, which will be marketed to immunology researchers and drug developers to accelerate their studies. These objectives are made possible by our team’s recent advances, overcoming barriers to the unbiased functional study of histone PTMs in human cells.